Hazardous chemicals and brain developmental plasticity

Infancy is an extended developmental process during which an enormous amount of information is incorporated into the brain. Thus, if the brain's capacity for experience-dependent growth and modification were degraded even slightly by low level exposures to Superfund chemicals, cognitive performance might be impaired for a lifetime. We hypothesize that brain plasticity emerging late in development will be a very sensitive biomarker for detecting subtle damage suffered by brain cells during earlier stages of brain development. To test this, we will employ a model using extensively to document the key role of experience in organizing behavioral abilities and synaptic circuits in young animals. We predict that rats exposed during pre- and early postnatal neural development to Superfund toxicants will show deficits in brain plasticity after weaning in lower doses than they would show defects in brain morphogenesis. Because this approach tests a broad functional endpoint of development, it is appropriate for real world mixtures of Superfund chemicals. If the experiments confirm diminished behaviorally-induced gene expression as a biomarker of threshold neurotoxic defects, this novel model would provide a rapid and efficient means of screening the mature nervous system for developmental damage.